Personalized Integrated Alcohol and Sexual Assault Prevention among College Students

PROJECT ABSTRACT
The overarching goal of this R01 is to test the efficacy of a behavioral intervention for heavy episodic drinking
(HED) and sexual assault among college students. Sexual and gender minority (SGM) students experience
sexual assault and engage in HED at even higher rates than their cisgender, heterosexual peers. Therefore,
tailored and personalized interventions are needed for HED and sexual assault to address the unique needs of
college students based on gender identity and sexual orientation. The Alcohol and Sexual Assault Prevention
(ASAP) program was developed by the research team with an NIAAA-funded planning grant (R34) and is the
only intervention that targets both HED and sexual assault (victimization risk reduction, perpetration
prevention, and bystander intervention training) in an integrated manner. ASAP provides tailored content on
alcohol use and sexual assault based on gender identity and sexual orientation using a social norms and
personalized feedback approach. Usability testing and findings from a randomized controlled pilot feasibility
trial suggest usability, feasibility, and preliminary efficacy and warrant rigorous randomized controlled trial
testing. ASAP is delivered in a brief, web-based format, and although short-term outcomes are promising,
more effort is needed to ensure long-term efficacy. Therefore, the current study includes an assessment of
ASAP as well as an innovative assessment of a 6-month booster (ASAP+Booster) session to determine the
most effective way to disseminate ASAP to colleges nationwide if found to be effective. The current study
includes the following aims: 1a) to test the efficacy of ASAP and ASAP+Booster among college students in
reducing HED and sexual assault both short- and long-term among three risk groups (1. cisgender
heterosexual men; 2. cisgender heterosexual women; 3. SGM); 1b) Test the relative efficacy of a booster
session on long-term alcohol use and SA outcomes; and 2) Investigate the mechanisms through which ASAP
conditions impact alcohol use and SA. Outcomes will be assessed at 3-, 6-, 9-, and 12-months post-
intervention. By accomplishing these aims, we will assess the efficacy of ASAP, a promising intervention
developed by the research team. ASAP has the potential to reduce alcohol use among young adults as well as
reduce college SA and includes a focus on SGM populations, addressing NIAAA and public health priorities.

Public health relevance
PROJECT NARRATIVE Heavy episodic drinking and sexual assault (SA) are problematic on college campuses and risk differs based on gender identity and sexual orientation. Alcohol and Sexual Assault Prevention (ASAP) is a web-based personalized feedback intervention for alcohol use and SA tailored based on risk group (cisgender heterosexual men, cisgender heterosexual women, and sexual/gender minorities). The current study will assess the short- and long-term efficacy of ASAP on heavy episodic drinking and SA among college students.